Linking Science, Mathematics and Literacy for All Learners

Linking Science, Mathematics and Literacy for All Learners (LSM&L4AL)
ABSTRACT
The proposed program will provide innovative educational resources to help redress significant
nationwide deficits in science, mathematics, and literacy learning, especially for grades 6-8
students with disabilities (SWD). These new resources will improve and extend the: 1)
multimodal STEM text sets: 2) virtual teacher professional development – communities of
practice (vPD-CoP); and 3) scenario-based assessments (SBAs) of scientific argumentation
developed by the current NIGMS/SEPA Linking Science and Literacy for All Learners program,
and that have garnered state and national recognition. Multimodal STEM text sets (1) are
coherent collections of content and instructional resources pertaining to an anchor phenomenon
and line of inquiry that support learners’: a) Engagement with a grade-band level complex
anchor text; b) Development of the science and disciplinary literacy skills called for by the
shared Next Generation Science Standards (NGSS) and Common Core State Standards
(CCSS) or state equivalents. The vPD-CoPs (2) help teachers, learn about, develop, and
implement multimodal STEM text sets for their diverse grade 6-8 learners. The SBAs (3) provide
quantitative data about the instructional interventions, and help teachers understand scientific
argumentation practices and include them in their instruction. Preliminary evidence supports the
hypothesis that appropriate instructional support with multimodal STEM text sets, helps diverse
students (particularly SWDs) engage with grade-band level complex anchor texts and improve
scientific argumentation skills that can be measured with SBAs. The proposed program will add
mathematics and research-generated data to all the program resources, and the effects will be
rigorously tested over five years with quantitative data from thousands of diverse students
nationwide, and with qualitative data of instructional implementation by teachers of science,
mathematics, English language arts and special education in diverse school settings,
nationwide. These resources and the research data will be disseminated widely by the program
website, in high profile journals, in books and reports, and at regional and national meetings, to
have a lasting impact upon inclusive and effective education for diverse students’ participation in
the biomedical workforce and contributions to society. The program faculty and consultants are
experienced educator/researchers in science, literacy, mathematics and special education with
a strong independent evaluation team and institutional support.

Public health relevance
Linking Science, Mathematics and Literacy for All Learners (LSM&L4AL) PROJECT NARRATIVE This project is focused on developing educational resources—multimodal STEM text sets—designed for middle school students to engage in and understand complex text. We will test the hypothesis that these resources, situated in life sciences topics, will result in improved diverse learners’ reading, mathematics, and scientific argumentation skills. These resources along with findings from the project will be disseminated widely and contribute to NIH’s and the nation’s overarching goal to “enhance the training of a workforce to meet the nation’s biomedical, behavioral and clinical research needs and especially of students from underserved communities.”